Role of translational fidelity in cellular physiology of oral streptococci

ABSTRACT
Ribosomes are composed of ribonucleoproteins and are essential for protein biosynthesis, which is one of
the most complex biological processes in the cell. In prokaryotes, mature ribosomes contain proteins (r-
proteins) and RNA (rRNA) that are assembled into the mature 70S ribosome. The 70S ribosomes are made
by two subunits, designated as the 30S (small) and the 50S ribosome (large) subunits. The small subunit is
composed of the 16S ribosomal RNA (rRNA) and over 20 core r-proteins while the large subunit is composed
of 23S and 5S rRNAs, and more than 30 core r-proteins. Ribosome is not a stationary entity, rather it is
adapted to changing environments giving rise to ribosome heterogeneity. Additionally, several small
accessory proteins modulate the biogenesis, recycling, and function of the ribosome; many of these proteins
and their molecular functions remain to be discovered.
During protein synthesis, translational fidelity is maintained with high accuracy. However, the average
translation error rate is relatively higher (10-4 to 10-3 per codon) compared to transcription or replication error
rates. Maintaining proper translational fidelity requires cognate pairing of amino acids and tRNAs by
aminoacyl-tRNA (aa-tRNA) synthetase and accurate decoding of mRNA codons by the corresponding aa-
tRNAs on the ribosome. Several core and accessory r-proteins drive the correct decoding of the codons to
maintain the translational fidelity. Various stress conditions such as nutritional and oxidative stresses often
lead to mistranslation and growth defects in bacteria. We have recently identified several factors including a
conserved novel protein, SprV (90 amino acids), in Streptococcus mutans (an oral pathogen) that is required
for translational fidelity, stress tolerance and adaptation. The major goal of this study is to understand at the
molecular level how SprV and other accessory proteins such as L9 (r-protein) and EF-P modulate
translational fidelity to alter physiology and biological fitness of oral streptococci.

Public health relevance
PROJECT NARRATIVE Protein translation is one of the most complex biological processes and maintaining fidelity during protein translation plays an important role during stress response and environmental adaptation in bacteria. The major goal of this project is to understand at the molecular level how some highly conserved novel accessory proteins are involved in translational fidelity in oral streptococci. This study will broaden our overall understanding on the molecular mechanisms of protein translation in streptococci and related organisms.